Reduced allelic dosage of CLP1 attenuates cognitive dysfunction and pathological burden in transgenic mouse models of Alzheimer’s disease

Project Summary/Abstract
Alzheimer’s disease (AD) is the most prevalent form of dementia in the elderly caused by complex interactions
of genetic and environmental risk factors. An estimated 130 million people will develop AD by 2050, constituting
an urgent clinical need for effective treatments and therapies to be developed. Prior therapies have focused on
resolving pathological hallmarks, such as senile plaques (Ab) and neurofibrillary tangles (tau), but have failed to
improve cognitive function in patients. The RNA kinase, CLP1, was recently found to be a genetic mediator AD.
Additionally, high mRNA levels of CLP1 correlated with poor cognitive function in patients. Our preliminary
histological analysis of brain samples from dementia patients and a mouse model of AD, with controls, found a
shared, aberrant expression pattern of CLP1 protein with disease. Together, these findings lead us to
hypothesize that CLP1 overexpression may contribute to AD pathogenesis and cognitive decline in AD.
To test this idea, we will intercross mouse models of AD with Clp1 heterozygous mutant mice and assess disease
pathology and cognitive decline during AD progression for amelioration.

Public health relevance
Project Narrative Alzheimer’s disease is the most common neurodegenerative disease, characterized by pathological deposits amyloid beta and hyperphosphorylated tau. Genetic and molecular studies have uncovered novel pathways implicated in disease risk; however, effective therapies to treat dementia have not yet been developed. The goal of the proposed study is to evaluate the impact of a putative therapeutic target gene on Alzheimer’s disease onset and progression in mice.